IMAGE: Neuroimaging to Investigate Brain Development in Children after Exposure to HIV and or Antiretrovirals

There is a growing number of children exposed to HIV who remain uninfected (CHEU) and increasing likelihood
of antiretroviral (ARV) use in pregnancy for either HIV treatment or prevention. Even a small impact of HIV or
ARV exposure on CHEU would have a large population-level effect in countries like Botswana, where 20% of
children are HEU. Drivers of neurodevelopmental differences observed among CHEU remain unclear.
Neuroimaging can assess neurobiological differences in children with differing HIV and ARV exposures. MRI
studies of young CHEU suggest structural brain differences compared to children without HIV exposure (CHU),
associated with functional outcomes like language. Yet, no longitudinal neuroimaging studies of CHEU map
brain development trajectories through older childhood into adolescence, despite ongoing brain growth, and data
from the era of dolutegravir (DTG) do not exist to date. Large, multi-country evaluations are especially needed
as population-level standard distributions of brain metrics and neurodevelopment scores are not yet defined. Our
proposal addresses key knowledge gaps by defining brain maturation of CHEU into adolescence for the first
time in a large multi-country cohort, identifying pathways for developmental differences (e.g., ARV, HIV
exposure), and clarifying the impact of neurobiological alterations among CHEU using novel MRI approaches
that are now accessible in HIV priority settings. We propose a significant advancement to our prior work—a well-
powered, prospective, multi-country, neuroimaging and neurodevelopment evaluation that leverages ongoing
CHEU cohorts in Botswana and Kenya with exposure to various ART regimens (e.g., EFV, TDF, DTG), children
who have only ARV exposure (PrEP), and children without HIV or ARV exposure. Our proposal is designed to
examine brain development in HIV priority settings and will create pediatric HIV neuroimaging repository in a
combined cohort to unravel neurobiological pathways following ARV/HIV exposure. We will extend follow up to
10 years with annual neuroimaging on all children (3 timepoints per child) to characterize brain metrics following
ARV and/or HIV exposure (Aim 1). We will also test the hypothesis that smaller brain volumes are associated
with poorer neurodevelopment in late childhood, especially in CHEU, by rigorously conducting standardized
assessments across domains (attention/executive function, learning and memory, complex cognition,
sensorimotor function, and processing speed) and testing whether domain scores differ by HIV and/or ARV
exposure (Aim 2). Finally, we will examine if brain metrics are associated with school performance and
neurocognition in adolescents who are HEU (Aim 3). Project 1 synergizes with the other U19 Projects by
examining neurobiological factors that influence development. Project 1 will provide a large repository of pediatric
neuroimaging data for future research, including neurobiological outcomes of other infectious diseases (e.g.,
malaria) and maternal exposures.